Studies in Translational Regenerative Medicine

Project Summary/Abstract
The Regenerative Medicine (RM) field requires a new type of researcher, well-trained in fundamental RM
concepts and methods, able to integrate human biology and engineered systems with awareness of challenges
involved in advancing basic research, regulatory science, and clinical translation. The overall goal of our T32
pre-doctoral training program, “Studies in Translational Regenerative Medicine”, remains committed to
developing next generation multidisciplinary trained research scientists and engineers, who will lead
new diverse research teams designing solutions to real-world health problems and advance the RM
field. Ability to link state-of-the-art multidisciplinary basic science training to the infrastructure and knowledge
base required to accelerate translation of RM technologies are key strengths. To date, this T32 program has
provided 10 PhD trainees the tools to become independent RM researchers. Consistent with faculty's
successful record of educating pre-, post-doctoral and early-career faculty, the first cycle of our T32 program
exceeded goals. Trainees accrued an impressive list of quality publications (66 published/14 in process) and
oral and poster presentations (103) at local, national and international meetings. Importantly, 100% of
appointed trainees are currently working on their PhD requirements or have obtained their PhD degrees. Six
trainees completed their T32 training and PhD defense and successfully moved on to academic or non-
academic careers. Of these, 4 (66%) remain in explicitly focused RM research. Three (50%) were recruited,
because of their T32 training, into industry positions with extensive RM portfolios. WFIRM's distinctive
infrastructure provides the facilities and expertise for translational studies ranging from basic preclinical studies
through Phase 2 clinical trials. WFIRM's multidisciplinary training includes a range of activities, including
didactic courses, participation in cutting-edge team science, and new opportunities to engage in academic,
government, and industrial externships. The new program emphasizes professional and career development,
including project and time management, grant writing, regulatory science, GMP manufacturing, and scientific
ethics. The program has 3 NIBIB-aligned focus areas: 1) biomaterials; 2) enabling technologies (bioprinting,
body-on-a-chip, imaging & multifluidics); and 3) stem cells/cell therapies applied to one or more application
areas: 1) cardiovascular; 2) musculoskeletal; 3) gastrointestinal/endocrinal; and 4) urological. Trainees are
selected from 4 of 7 WFGS tracks: Biomedical Engineering, Molecular & Cellular Biosciences, Neuroscience or
Integrative Physiology and Pharmacology. After a common 1st year curriculum (unique to each track), trainees
identify one of 10 primary mentors (of 19 mentoring faculty), take specialized RM courses and choose a
graduate committee. Inclusion of seasoned Primary Mentors (10), Mentors-in-Training (6), and Emeritus
Mentors (3) with career-long mentoring experience is a unique program aspect. The program is reviewed by
Internal and External Advisory Boards composed of prominent academic, government, and industry members.

Public health relevance
Project Narrative This program aims to train graduate students on the path to obtaining their PhDs to become translational research scientists and engineers who can integrate human biology and engineered systems to investigate and develop new technologies, diagnostics, and experimental therapeutics in patients and model disease systems. This competing renewal of our pre-doctoral training program in translational regenerative medicine remains a logical extension of the ongoing collaborative multidisciplinary research of the institute's outstanding faculty. WFIRM's unique infrastructure provides pre-doctoral trainees' access to RM experts and state-of-the- art facilities, allowing these trainees to be properly educated in the multidisciplinary field of RM, from basic science to translational applications, including the development of Phase 1 and 2 clinical trials.